Cognitive control targets for the treatment of obsessive compulsive disorder in young children

Abstract. Obsessive-Compulsive Disorder (OCD) often onsets in childhood and, if not effectively treated,
can lead to lifelong illness and poor functional outcomes. Cognitive behavioral therapy (CBT) with
exposure and response prevention (EXRP) is the gold-standard, first-line treatment for children with
OCD, however, as many as 40% of pediatric patients fail to remit. EXRP requires children to deliberately
experience distress associated with their obsessions while refraining to engage in their usual compulsive
rituals aimed at reducing or neutralizing distressed. Thus, to be effective, EXRP depends on the patient's
capacity to flexibly adapt thinking and behavior, i.e., to engage cognitive control. Our preliminary data
and the extant literature show an altered capacity for cognitive control and altered functioning of
underlying task control (TC) circuits in children with OCD. This proposal leverages a child-friendly,
engaging, computerized at-home cognitive training (CT) intervention to enhance cognitive control
capacity (target engagement) to reduced symptoms and improve EXRP response in children with OCD.
In the R61 phase, CT will be delivered to 60 children (8 to 12 years) with OCD to test improvements in
behavioral markers of cognitive control; significant within-person improvement in cognition is the Go/No-
Go Criterion to progress to the R33 phase. The R61 will also probe optimal dosing as this is the first
study to test this intervention in pediatric OCD. Specifically, we will probe change in cognitive
performance after 2 and 4 weeks of training; 4 weeks is the dose previously used in children with ADHD.
The R33 will entail a double-blind randomized control trial in 120 children (8 to 12 years) with OCD.
Children will be randomized to complete the optimal dose of CT, per the R61, or a sham training
matched for experience but not targeting cognitive control. All children will then complete 12 weeks of
gold-standard manualized EXRP. This will allow us to probe how active CT engages our behavioral
target and augments response to EXRP, compared to a sham control. We will further explore changes in
task control to default mode network connectivity pre- to post-CT as a likely neural mechanism of action.
Using this CT with a novel population and evaluating how changes in neuroscience-derived targets relate
to changes in OCD symptoms in children directly responds to NIMH call for experimental therapeutics
and addresses an urgent need for novel interventions to treat OCD. Furthermore, computerized, at-home
CT represents a highly scalable intervention both to augment existing treatments as well as having
potential as an early intervention before onset of severe illness.

Public health relevance
Project Narrative Cognitive behavioral therapy with exposure and response prevention is highly effective for children with OCD, yet not all children will fully remit. Exposure therapy requires leveraging extensive cognitive control, which is shown to be altered in youth with OCD. This project will leverage a child-friendly, computerized, at-home cognitive training program in 8–12-year-olds with OCD to enhance the capacity for cognitive control (target engagement) and augment response to exposure therapy.